Advancing the functional maturity of brain organoids by synthetic afferentation.

PROJECT SUMMARY
Human pluripotent stem cells (hiPSCs) are a powerful tool for understanding the principles that govern the
development of the human brain and for modeling diseases of the nervous system. One important recent
application of this technology is the generation of tri-dimensional (3D) brain cell cultures or "organoids." Brain
organoids have been shown to develop structural, transcriptional, and functional similarities up to the mid-to-late
gestation human brain as compared to preterm human EEG recordings and human transcriptome profiles.
Currently they represent the closest cellular model to native human brain tissue available. While a powerful
system for probing mechanisms of prenatal development attempts to advance the maturation state of brain
organoids have proved to be incremental, inconclusive, or poorly reproduced. As a result, brain organoid systems
remain largely inappropriate for modeling the postnatal brain. There is a significant need to develop a new
generation of brain organoid models that are appropriate for interrogating later developmental stages. This
proposal focuses on understanding the role of physiological inputs as a necessary driver of more robust,
reproducible, and mature physiological states of activity in brain organoids. This project will develop approaches
for introducing developmentally-relevant inputs and for reading out neuronal activity in human brain organoids.
Extensive work from other systems has established that afferent network activity serves to establish, maintain,
and refine active functional brain circuits. Here, we will test a series of innovative strategies to replace or mimic
missing external inputs via prolonged patterned stimulation of human brain organoids. We will then observe the
resulting effects on network activity and gene expression. We will benchmark these observations to existing data
sets from human cortical organoids as well as the human and rodent brain. The tools and approaches established
here are intended to be readily adapted to cell culture models of other organ systems for which neuronal inputs
are important. If successful, this project will establish a novel platform for interrogating activity-dependent
maturation and will enable access to more advanced stages of human brain development and human
neurological and neuropsychiatric disease states.

Public health relevance
PROJECT NARRATIVE Tri-dimensional (3D) cellular structures derived from human stem cells have been shown to recapitulate many aspects of fetal brain development; however, current approaches stall during late gestation and fail to reproduce the more complex brain activity associated with the mature brain. We will introduce missing inputs into these models as a strategy to promote more complex brain maturation. The goal is to lay the foundation for the next- generation of human brain modeling to enable more relevant modeling of the normal brain and neurological and neuropsychiatric disease mechanisms.